An Intervention to Promote Positive Peer Relationships and Reduce Prejudice and Bias in Childhood

Project Summary/Abstract
The proposed project will use a multi-site within-school randomized control trial (RCT) intervention design to
promote positive intergroup relationships and to reduce prejudice in childhood. The health consequences for
children who experience discrimination (e.g., name-calling, bullying, exclusion) as a result of prejudice include
compromised health and well-being, stress and anxiety, and social withdrawal. Further, individuals who
perpetuate bias (i.e., hold biases about social groups that restrict their social interactions) also experience
health-related stress associated with negative intergroup relationships in school settings. Thus, reducing
prejudice and bias in childhood has positive health, attitudinal, and academic outcomes for all children.
Extensive developmental science research has shown that implicit bias (negative attitudes toward other social
groups of which the beholder is unaware) and explicit biases (stereotypes) emerge as early as the preschool
period and become more pervasive by late childhood, particularly as justifications for social exclusion.
Research has provided evidence that positive contact with peers from different ethnic, racial, and cultural
backgrounds effectively reduces prejudice and bias. Given the prevalence of bias-based social exclusion
among children, the goal of the project is to promote positive intergroup contact and reduce biases and
stereotypes in childhood. Participants will be 3rd, 4th, and 5th grade students (8 – 11 years of age; N = 1,440) in
72 classrooms in 12 schools in a large public school district outside of a large metropolitan area. The sample
will be racially and ethnically diverse and include European-American, African-American, Latino/a, Asian-
American, and multiracial students, who will be randomly assigned to an intervention program or a control
condition (Business-as-Usual). The 10-week program involves the use of an in-classroom web-based
curriculum tool called Developing Inclusive Youth, in conjunction with teacher-led classroom discussion
sessions. Children make decisions and observe the outcomes of their own decision-making as the action
unfolds contingent on their inclusion or exclusion choice while using the app. The pre-test post-test measures
include socioemotional (school belonging, peer and teacher support, ethnic and gender public regard) and
intergroup attitudes (social exclusion evaluations, and diversity in friendship choices). Analyses will utilize
mixed modeling using restricted maximum likelihood estimation. We expect that, compared to the control
group, children in the intervention program will have higher socioemotional scores and lower intergroup bias
scores following the intervention. The benefits of decreasing prejudiced attitudes will be promotion of healthy
social and emotional development of children.

Public health relevance
Project Narrative (relevance to public health in 3 sentences) PI: Melanie Killen; Co-I: Tracy Sweet The goal of this intervention project is to promote positive relationships and reduce prejudice and bias in childhood. The health consequences for children who experience discrimination (e.g., name-calling, bullying, exclusion, relational aggression) as a result of prejudice include compromised health and well-being, stress and anxiety, and low academic achievement. Stereotypes and biases are deeply entrenched by adulthood; thus, the time for intervention is childhood, when attitudes and behaviors are emerging and intervention will have its maximum impact.